Stakeholder-Partnered Implementation Research and Innovation Translation (SPIRIT) program

PROJECT SUMMARY/ABSTRACT
As a collaboration among UCLA, Kaiser Permanente Southern California, the VA Greater Los Angeles
Healthcare System, and the LA County Department of Health Services, the proposed new AHRQ-PCORI K12
program, Stakeholder-Partnered Implementation Research and Innovation Translation (SPIRIT), is
designed to prepare outstanding postdoctoral scholars (including MD, PhD, MD/PhD, ScD, DrPH, and
PharmD) for academic research careers focused on rapid and sustainable uptake of new scientific discoveries
and innovations that improve the design, delivery, and outcomes of care for chronic diseases at the individual,
population, and health care system levels. In the current era of declining numbers of health scientists nationwide,
particularly among clinical providers, and of expanding need to bridge research and practice across diverse
real-world settings of health services and systems as well as demographically diverse populations, SPIRIT will
fill a critical need for research on a broad range of issues in the generation, dissemination, and implementation
of clinical evidence and will advance the goals of increasing the pace and volume of innovation in the
diagnosis, treatment, and prevention of chronic diseases to facilitate and advance learning health systems. In
response to the challenges of better understanding variation in practice and outcomes and the barriers of T4
translation, the interdisciplinary curriculum and mentored hands-on research opportunities of the new K12
program interweave the scientific expertise and mentoring experience of 24 high-quality multidisciplinary
investigators who are committed to collaborative, team-based cross-training and research in health services
and patient-centered outcomes, clinical epidemiology, and dissemination and implementation. SPIRIT will
leverage topically germane resources of education, training, and career development programs extant among
the four partners for the core curriculum and protected time, foremost, the UCLA National Clinician Scholars
Program, to achieve the following specific aims: (1) expand the multidisciplinary knowledge base of evidence-
based practice and learning health systems as it relates to different aspects of chronic disease care across the
clinical spectrum; (2) provide didactic and hands-on research training/career development in the intellectual
and philosophical foundation of rapid translation of evidence into practice within the broader research
enterprise of translational medicine; (3) develop scholars' scientific writing skills for presentations, publications,
and grants; (4) provide an academic environment that enables development of the research skills and
experience needed for successful, independent scientific careers as members and leaders of interdisciplinary
teams dedicated to improving patient and population outcomes and health system performance; and (5) model
research-empowering teaching and mentoring skills for scholars' development, including their eventual
replication of research education, training, and career development programs in health system stakeholder-
partnered improvements of chronic disease care as their careers evolve into stable, scientific independence.

Public health relevance
PROJECT NARRATIVE Through mentored research career development of the next generation of interdisciplinary team members, leaders, and innovators in dissemination and implementation science and learning health systems, the Stakeholder-Partnered Implementation Research and Innovation Translation (SPIRIT) K12 Program will advance our knowledge of delivery and implementation strategies for proven interventions in real-world practice and community settings. In closing the gap between evidence-based interventions and their uptake across diverse settings and populations, including historically underserved populations who manifest wide disparities in health status, SPIRIT will contribute to improved health system performance as well as patient outcomes and overall quality of life of adults and children, and their families, who live and often struggle with a broad range of chronic conditions.